Chromatin state contributions to cytoplasmic incompatibility

Project Summary
Among all endosymbionts, maternally transmitted Wolbachia bacteria are the most common, due in large part
to their ability to influence host reproduction to spread. Many Wolbachia cause cytoplasmic incompatibility (CI),
a sperm modification that kills embryos without Wolbachia. Two prophage-associated genes (cifA and cifB)
cause and one gene (cifA) rescues CI. Cytologically, CI produces cycle-1 defects in embryogenesis when
paternal chromosomes fail to properly condense. However, CI-derived embryos regularly escape cycle-1
defects and display chromosome segregation defects later in embryogenesis during the cortical divisions (10-
14). Further, some individuals fully escape CI, proceeding to larval and even adult life stages. This has resulted
in a large gap in knowledge about whether a common acute CI mechanism acts at different time points, or if
independent and temporally distinct mechanisms underlie these patterns. The proposed research will fill this
gap in knowledge by integrating genetic, cytogenetic, and genomic analyses to determine the primary cellular
defect underlying embryonic lethality in the context of two mechanistic models. The host-modification (HM)
model predicts that Cifs modify male gametes prior to fertilization, while the toxin-antidote (TA) model predicts
that Wolbachia produce a Cif toxin that is transferred directly to the embryo. The presence of independent
defects beyond cycle-1 lends support to the HM model since a putative toxin is unlikely to persist throughout
embryogenesis. Elegant experiments have tracked cycle-1 mitotic defects to errors at the histone-protamine
transition in spermatogenesis that cause abnormal levels of paternal histones in sperm nuclei. Very recent data
also indicate a reduction of H3K9me2,3—a marker of inactive heterochromatin—in CI crosses. These data
support the hypothesis that CI-causing Wolbachia modify host chromatin and interfere with the histone post-
translational-modifications (PTM) required for normal histone removal. The proposed work will determine if
histone PTMs are maintained through development in embryos and larvae which ‘escape’ embryonic death.
Chromosome structure will then be evaluated in larvae to determine the relationship between histone PTMs
and decondensed chromosomes. To determine the genome-wide effects of CI-induced chromatin changes,
chromatin accessibility in embryos will be mapped using single-cell ATAC-seq. This technique was chosen to
specifically identify differentially condensed genomic regions in the presence of Wolbachia. Finally, a Position
Effect Variegation screen will be used to assay effects on gene expression as a functional output of the
chromatin states. In addition to preparing the applicant for a long-term career as a principal investigator, this
work will fill critical gaps in knowledge by tracking the chromatin state changes that occur with CI and
determining if a single mechanism underlies CI death. This work will contribute to our broader knowledge of CI,
which is critical for explaining global Wolbachia prevalence in natural populations and to improving the efficacy
of Wolbachia biocontrol of human disease transmission in transinfected vector populations.

Public health relevance
Project narrative Maternally transmitted Wolbachia bacteria associate with most insects, making them the most common endosymbionts in nature. Many Wolbachia cause cytoplasmic incompatibility (CI), a sperm modification that kills embryos without Wolbachia and spreads Wolbachia to high frequencies, including in transinfected mosquito populations where pathogen-blocking Wolbachia are leveraged to reduce human disease transmission. The proposed research will determine the primary cellular defect underlying embryonic lethality in the context of two mechanistic models.